Uteroplacental Vasculature and Fetal Growth after Plastic Particle Exposure

PROJECT SUMMARY/ABSTRACT
In humans, fetal growth restriction (FGR) and impaired placental development are associated with infant
morbidity and mortality and susceptibility to adulthood diseases. In pregnant animals, inhalation of particles alters
the functionality of the uteroplacental vasculature, leading to impaired placental and fetal growth. Particulate
matter (PM) can target the uteroplacental vasculature in multiple ways. One way by which particles can disrupt
the uteroplacental vasculature is by impairing vasodilation. During pregnancy, uterine vessels must be sensitive
to vasodilation mediators to meet the dynamic needs of the placenta and fetus. Central to this vasoreactivity is
the endothelial cell that translates signals from the blood to the vascular smooth muscle cells, leading to vessel
dilation or constriction. Additionally, the placenta is a critical organ for the diffusion of oxygen and transport of
nutrients to the developing fetus. PM can impair development of the placental vasculature that allows for
maternal-fetal exchange and decrease the ratio of placental-to-fetal tissue, known as placental efficiency. Our
laboratory recently showed that plastic particles can translocate through the placenta to the fetus after pulmonary
exposure, suggesting that the particles directly interact with the uteroplacental vasculature. The environmental
burden of plastics is exponentially increasing. Micro’ nanoplastics (MNPs) represent a ubiquitous exposure
concern for the general population and for vulnerable groups, such as pregnant women, it is important to
elucidate how MNP inhalation may affect fetal development. These particles are generated and suspended in
the air by the combustion of bulk plastic or through slower processes like mechanical degradation where a bulk
plastic fragments into small pieces in the microparticle (>100 nm) and nanoparticle (<100 nm) size range. Our
preliminary data demonstrates that MNP inhalation in virgin female rats disrupts uterine vascular reactivity.
Furthermore, using a pregnancy model of MNP inhalation throughout gestation, we observed FGR, increased
placental weight, and decreased placental efficiency suggesting the placenta is a target organ of MNPs in rats.
Therefore, the central hypothesis of this proposal is that maternal inhalation of MNP throughout gestation
decreases placental efficiency by impairing uterine vasodilation and disrupting development of the placental
vasculature in rats. The aims in this proposal will investigate the mechanisms by which repeated maternal MNP
inhalation dysregulates the uterine vasculature and placental development, thus contributing to FGR. Aim 1 will
identify mechanisms of impaired uterine vascular reactivity and how endothelial cell function is altered after
maternal MNP exposure. Aim 2 will determine how maternal MNP inhalation modifies development of the
placental vasculature using histopathological analyses and immunohistochemistry. This research will identify
mechanisms of MNP induced FGR and present potential targets for therapeutic intervention. By completing the
proposed research, courses, and training the Principal Investigator will be trained independently conduct state-
of-the-art experimental techniques and carry out cardiovascular and reproductive toxicological research.

Public health relevance
PROJECT NARRATIVE The exposure of mothers to harmful agents during pregnancy can lead to poor growth of their babies. My research investigates how a mother’s uterus and placenta is impacted by plastic particles within polluted air and how these changes lead to babies that are smaller.